Multiscale Computational Modeling to Design Patterned Tissue Assembloids for Biomanufacturing

PROJECT SUMMARY
The mass production of tissues and organs is the ultimate goal of biomanufacturing, but this goal will not be
achieved without the assistance of engineering design tools that predict how three-dimensional, multicellular
structures, comprised of cells that dynamically respond to each other and their environment, self-organize into
spatially patterned tissues. To date, no such design tools exist, and our high-risk, high-reward proposal seeks
to develop and validate the first multiscale computational model to inform the design, fabrication, and self-
assembly of tissues comprised of heterogeneous cell types engineered with synthetic gene circuits regulating
cell adhesion. We recently published a relatively simple agent-based computational model, that when coupled
with machine learning algorithms, identifies design parameters that generate multicell spheroids, or simple
tissues, comprised of heterogeneous subpopulations of cells that self-organize into specific patterns (e.g.,
striped, soccer ball, core/shell, and core/pole). The proposed work will greatly elaborate this simple model to a
multiscale computational model to predict how collections of bioprinted spheroids form into spatially patterned
“assembloids.” We will utilize mixed populations of two cell types genetically engineered with highly modular
synNotch synthetic gene circuits, which propagate intracellular signals to regulate cell-cell adhesion strength
based on cell-cell interactions. We will also leverage state-of-the-art 3D printing spheroid positioning
technology developed at our institution to precisely place three-dimensional spheroids adjacent to one another
within a synthetic biomaterial that facilitates the formation of engineered tissue constructs. In Aim 1, we will
develop a novel multiscale agent-based computational model that predicts how synNotch-mediated
intercellular signaling and intracellular signaling in individual cells gives rise to self-sorting of heterogeneous
cell populations, leading to the emergent patterning of three-dimensional tissues. We will run tens of thousands
of simulations and apply clustering algorithms to extract design parameters that favor certain three-dimensional
tissue patterns over others. In Aim 2, we will experimentally validate that the computational model can be
reliably used to design three-dimensional multicellular tissue constructs by challenging it to identify the design
parameters (e.g., initial number of cells, ratio of cell subpopulations, heterotypic and homotypic cell-cell
adhesion strengths) that will generate three-dimensional assembloids with specific multicellular patterns. We
will culture synNotch cells into spheroids and spatially position them into tissue assembloids according to the
design parameters predicted by the computer model, and then we will assess if the experimental tissues,
imaged using confocal microscopy, exhibit the spatial patterns predicted by the computational model. We
expect that our project, which tightly integrates computational modeling with experiments, will significantly
advance the fields of three-dimensional bioprinting, biomanufacturing, and multiscale computational modeling
of multicellular tissues and enable the robust generation of complex tissue structures by design.

Public health relevance
PROJECT NARRATIVE Biomanufactured tissues hold significant promise for the future of organ transplantation and drug discovery. However, engineering algorithms are needed to design three-dimensional multicellular tissues that will evolve with specific structural configurations or patterns as cells signal one another to undergo phenotypic changes. This project will fill that void by establishing and validating the first multiscale computational model for predicting and designing multicellular tissues comprised of cells whose behaviors are regulated by engineered signaling circuits controlling cell-cell adhesion.